High-resolution flexible mobility analyzer for point-of-care diagnostics

PROJECT SUMMARY
This project aims to address the current gap in technology for rapid lipids profiling. A point-of-care
technology that provides quick detection will impact healthcare management by leveraging patient’s
proactive participation. In pursuance of this goal, we will develop an ion mobility chemical analysis
technology, which provides chemical information with molecular level specificity, for disease
diagnostics and monitoring and identification of pathogens. The project will focus on a proof-of-
concept technology for a portable molecular analyzer device that can be utilized to analyze breath,
saliva, blood pricks in its mature stage for markers of disease. The new device will be designed
based on extensive ion trajectory simulations that will provide the geometrical as well as optimal
operating parameters. Optimal designs will be used to build prototypes that will be evaluated in terms
of sensitivity and selectivity for detecting targeted molecules to demonstrate a working prototype in
conjunction with a mass spectrometer.

Public health relevance
PROJECT NARRATIVE This project will develop a compact high resolution atmospheric pressure ion mobility analyzer for point-of-care diagnostics and disease progression monitoring. Guided by theoretical modeling this project will provide the proof-of-concept experiments for the new device. The performance evaluation will include the sensitivity and resolution of individual lipids and their mixtures.